Noninvasive assessment of the cornea by diffusion OCT

Keratoconus is a degenerative disease of the cornea that is a major cause of reduced vision-related
quality of life in the United States, often leading to corneal transplantation. Ectasia after refractive surgery is a
vision-threatening complication that can occur in apparently low-risk patients despite current screening
technology. The biomechanical properties of the cornea play a central role in these diseases, but diagnostics
are still rooted in shape measures because doctors lack direct measures of biomechanical change. While
several methods have shown early promise for addressing this gap, most require contact with or perturbation
of the cornea, cannot spatially resolve biomechanical properties, or involve expensive optical systems.
To address the need for direct biomechanical measurement of the cornea and the limitations of other
approaches, we introduce phase-decorrelation OCT (phd-OCT). Phd-OCT makes use optical coherence
tomography (OCT) to quantify random nanoscale mobility that is related to the strength and cohesion of the
cornea. Preliminary results strongly support the rationale, feasibility and potential advantages of the approach.
Our objectives are: (1) to refine our method to optimize detection sensitivity and speed, and (2) to
determine if the technique is clinically useful. We will achieve these objectives through the following aims:
1. To develop and validate mobility-sensitive phd-OCT for corneal imaging. Spectral-domain OCT will be
used for anterior segment phase-decorrelation imaging and the analysis algorithm will be optimized. The
system will be validated using phantoms and torsional rheometry.
2. To investigate the potential influence of physiological factors (intraocular pressure (IOP), hydration, and
temperature). Factorial design experiments in porcine and human donor globes will establish the sensitivity of
phd-OCT measurements to potential confounders.
3. To develop and validate data acquisition and processing methods to enable clinical testing. GPU
processing and machine learning will be configured to minimize processing time. Scan patterns will be
optimized to minimize scan time and return clinically useful data.
4. To assess feasibility and preliminary diagnostic performance of clinical mobility-sensitive OCT imaging
of the cornea. A first-in-human study will characterize repeatability and test the hypotheses that phd-OCT
mobility measurements are increased in the region of a LASIK flap and decreased in CXL.
Expected Outcomes: The proposed studies will establish a new, non-contact method for imaging corneal
biomechanical properties with the potential to address many shortcomings of current and emerging methods.
Success could lead to earlier detection of of ectasia risk and allow more appropriate timing and customization
of corneal treatments. Future integration of data into computational models has the potential to greatly impact
the field by driving a shift from empirical planning and risk analysis to patient-specific strategies.

Public health relevance
The mechanical properties of the cornea, the transparent front of the eye, are important for diseases that affect vision as well as for corrective treatments like crosslinking therapy and LASIK. We have developed a new optical coherence tomography (OCT)-based method to detect and map corneal mechanical properties that has advantages that may make it readily translatable to clinical use. The objective of this proposal is to determine whether this technique is clinically feasible and useful by refining the technology, testing it in animal and human donor corneas, and performing studies in patients with corneal conditions of interest.